Effect of PDE5 inhibitor on respiratory symptoms in COPD complicated by pulmonaryhypertension

Chronic Obstructive Pulmonary Disease (COPD) is the fourth leading cause of death in the US and is
common among Veterans. Dyspnea, a debilitating symptom of COPD, dramatically worsens health related
quality of life, is associated with a reduction in daily physical activity and greater health care utilization and
is more closely associated with survival than severity of airflow limitation. Thus, it is important to have
effective treatments that reduce dyspnea for Veterans with COPD. Pulmonary hypertension (PH) is a
common complication of COPD that is associated with severe dyspnea, more frequent acute
exacerbations of COPD, and increased mortality. There are multiple causes of PH associated with COPD
(COPD-PH), including decreased bioavailable levels of the vasodilator nitric oxide (NO).
Phosphodiesterase type-5 inhibitor (PDE-5i) therapy restores NO signaling and improves
cardiopulmonary hemodynamics and dyspnea among patients with Pulmonary Arterial Hypertension.
However, studies of PDE-5i medications in COPD-PH have shown conflicting results due to differing doses
or durations of therapy and differing definitions of PH. In a prior study (ClinicalTrials.gov.identifier:
NCT01862536), we investigated the effects of up to 12 months of oral PDE-5i therapy with tadalafil on 6
minute walk distance (6MWD), a measure of exercise capacity in Veterans with COPD-PH, in a multi-
center randomized placebo-controlled trial funded by the Department of Veterans Affairs. While tadalafil
did not change 6MWD at 6 and 12 months (the primary outcome), the treatment group experienced
changes in important secondary outcomes, with clinically meaningful improvement in patient-reported
dyspnea and COPD-related health related quality of life after 6 months of therapy. Additionally, over 6
months, dyspnea worsened in the placebo group, and patients receiving PDE-5i therapy suffered fewer
exacerbations. A limitation of this study was its small sample size. Given the importance of mitigating
dyspnea among patients with COPD, we will assess the effect of maximally tolerated therapy with tadalafil
specifically on dyspnea powered as a primary outcome. In 126 participants with COPD-PH (63 treatment
and 63 placebo) receiving usual clinical care for COPD, we propose to evaluate effects of tadalafil on
dyspnea among patients with COPD-PH in a prospective, double-blind, placebo-controlled clinical trial.
Aim 1: As primary outcome, we will determine whether 6 months of daily oral tadalafil is more effective
than placebo in reducing severity of patient-reported dyspnea, assessed by the University of California-
San Diego Shortness of Breath Questionnaire (UCSD-SOBQ), in Veterans with COPD-PH. We
hypothesize that patients receiving tadalafil will report less dyspnea than those receiving placebo.
Aim 2: As a secondary outcome, we will determine the effectiveness of tadalafil therapy on physical
activity, assessed by objective daily step count, and functional capacity, assessed by 6MWD. We
hypothesize that patients on tadalafil therapy will have improved physical activity and functional capacity.
Aim 3: As a secondary outcome, we will also assess the effects of tadalafil therapy on time to clinically
important deterioration, a validated composite outcome defined as increase > 4U in the total health-related
quality of life (St. George’s Respiratory Questionnaire, SGRQ), decreased FEV1 of > 100ml, or moderate-
severe acute exacerbations of COPD. We hypothesize that Veterans with COPD-PH receiving tadalafil
will be less likely to have clinically important deterioration.
Aim 4: In exploratory analyses, we will assess whether changes in noninvasive measures of PH (CT scan,
cardiac echo) are associated with changes in dyspnea. We hypothesize that patients receiving tadalafil
will have decreased PA/A ratio on CT scan, and decreased ePASP on echocardiography.
This study may provide evidence for a new therapy for dyspnea in COPD complicated by PH.

Public health relevance
We will study whether the drug tadalafil improves shortness of breath in 126 Veterans with Chronic Obstructive Pulmonary Disease (COPD) and high blood pressure in the lungs. We will also assess whether tadalafil improves quality of life, home daily physical activity, exercise endurance, the frequency of acute flares of COPD, blood pressure in the lungs, and lung function. Veterans who enroll in the trial will be allocated by chance to either active tadalafil or an inactive identical capsule (placebo). Neither the Veteran nor the investigator will know whether the Veteran is taking tadalafil or placebo. Veterans will be followed closely in clinic or by telephone at 1, 2, 3, 4, 5, and 6 months, with attention to side effects and safety. At 1,3, and 6 months we will repeat the questionnaires and testing of blood pressures in the lung and lung function. We anticipate that the results of this study will determine whether tadalafil improves shortness of breath when added to usual medications for COPD.